Training in Cellular & Molecular Biology

Abstract
The Cellular and Molecular Biology (CMB) training program offers doctoral candidates a multidisciplinary
education in molecular and cellular biology at institutions located within the Seattle biomedical corridor.
Administered out of the University of Washington (UW), this interdisciplinary program also supports predoctoral
trainees at the Fred Hutchinson Cancer Research Center (Fred Hutch) and partner institutions. The primary
objectives of the CMB program are to recruit a diverse group of enthusiastic and motivated students who are
passionate about the biomedical sciences and to provide personalized training across a range of disciplines
pertaining to basic and translational aspects of molecular and cellular biology. These talented individuals have
the opportunity to be mentored by 63 faculty members who are experts in a range of disciplines. Students are
drawn from seven participating graduate programs that include Biochemistry, Genome Sciences, Immunology,
Microbiology, Molecular and Cellular Biology, Neuroscience, and Pharmacology. CMB trainees enter the
program in Year 2 of graduate school after holistic selection through written and oral components of the annual
application competition. Trainees complete mandatory coursework in biostatistics and fundamentals of
molecular biology; participate in the Biomedical Research Integrity Lecture series; attend a monthly student
organized research conference with speaking and networking opportunities; receive training in scientific rigor
and reproducibility, gain scientific writing skills, participate in a peer mentoring program and take part in the
annual CMB Training Grant retreat. Traditionally, the CMB program has successfully partnered with several
minority advocacy groups to promote diversity on all campuses. We continue to expand the under-represented
minority (URM) footprint and are now additionally emphasizing the recruitment and retention of students who are
the first in their families to attend college (first generation) and students with disabilities. This innovative graduate
training environment encourages trainees to pursue scientific excellence and endorses peer mentorship and the
exploration of alternative career paths. The intended outcome is to nurture a diverse close-knit group of students
who are equipped to become the next generation of scientific leaders.

Public health relevance
Project Narrative This program trains students to understand both the life of a cell at the molecular level and how this relates to human health. This is achieved through a combination of formal lectures, mentored laboratory-based research, and group-learning experiences, with a foundation of scientific rigor and transparency. The anticipated outcome of this educational experience is to nurture a diverse, close-knit group of students who are equipped to become the next generation of outstanding scientists in a variety of careers.